ERV3 Control of Human Placentation

DESCRIPTION (provided by applicant): The genome of most vertebrates and some invertebrates has been transformed over millions of years by the integration of infectious retroviruses. Inheritable integrations into the genome of germ cells may have led to rapid evolutionary changes as the host accommodated and used advantageous retroviral proteins. Approximately 8% of the human genome is of apparent retroviral origin. A small number of endogenous retrovirus (ERV) integration sites retained isolated transcriptionally active open reading frames so that a variety of gag (matrix and capsid), pol (polymerase and other enzymes), and env (envelope) proteins may be expressed. The developing placenta is one of few organs that express ERV proteins under physiologic conditions. ERV3 is a single copy ERV genome with an open reading frame in the env region that is expressed during normal human villous cytotrophoblast differentiation. We determined that ERV3 env expression, through a cAMP/protein kinase A dependent pathway, is essential for expression of β-hCG in the syncytiotrophoblast. Results of our preliminary studies indicate that the active site is located in the N-terminal portion of ERV3 Env (referred to the p25 region), a unique finding related to retroviral Env proteins in general. Transfection of siRNA targeted to ERV3 env completely blocks induction of β-hCG. Our published and preliminary data support a hypothesis that ERV-3 env expression is essential for normal trophoblast differentiation and implantation through regulation of β -hCG expression. The goal of this R21 is to obtain certain critical data must be obtained in support of a future RO1. AIM 1. Mechanism of action of ERV3 Env on β-hCG expression. We will investigate the pathway through which ERV3 env expression affects expression of β-hCG. We will determine whether this pathway is activated through intracellular complex formation between ERV3 Env and co-factors or accessory molecules. We will also investigate an alternative secreted ERV3 Env-receptor mediated process. AIM 2: Effects of ERV3 env expression of the β -hCG promoter. Activation of the β-hCG promoter may occur secondary to cAMP-dependent transcription factors or directly if ERV3 Env is a transcription factor. Studies will evaluate both potential processes.

Public health relevance
PUBLIC HEALTH RELEVANCE: The genome of most vertebrates and some invertebrates has been transformed over millions of years by the integration of infectious retroviruses. Inheritable integrations into the genome of germ cells may have led to rapid evolutionary changes as the host accommodated and used advantageous retroviral proteins. Approximately 8% of the human genome is of apparent retroviral origin. A small number of endogenous retrovirus (ERV) integration sites retained isolated transcriptionally active open reading frames so that a variety of gag (matrix and capsid), pol (polymerase and other enzymes), and env (envelope) proteins may be expressed. The developing placenta is one of few organs that express ERV proteins under physiologic conditions. ERV3 is a single copy ERV genome with an open reading frame in the env region that is expressed during normal human villous cytotrophoblast differentiation. We determined that ERV3 env expression, through a cAMP/protein kinase Adependent pathway, is essential for expression of β-hCG in the syncytiotrophoblast. Results of our preliminary studies indicate that the active site is located in the N-terminal portion of ERV3 Env (referred to the p25 region), a unique finding related to retroviral Env proteins in general. Transfection of siRNA targeted to ERV3 env completely blocks induction of β-hCG. Our published and preliminary data support a hypothesis that ERV-3 env expression is essential for normal trophoblast differentiation and implantation through regulation of β -hCG expression. The goal of this R21 is to obtain certain critical data must be obtained in support of a future RO1. AIM 1. Mechanism of action of ERV3 Env on β-hCG expression. We will investigate the pathway through which ERV3 env expression affects expression of β-hCG. We will determine whether this pathway is activated through intracellular complex formation between ERV3 Env and co-factors or accessory molecules. We will also investigate an alternative secreted ERV3 Env-receptor mediated process. AIM 2: Effects of ERV3 env expression of the β -hCG promoter. Activation of the β-hCG promoter may occur secondary to cAMP-dependent transcription factors or directly if ERV3 Env is a transcription factor. Studies will evaluate both potential processes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The genome of most vertebrates and some invertebrates has been transformed over millions of years by the integration of infectious retroviruses. Inheritable integrations into the genome of germ cells may have led to rapid evolutionary changes as the host accommodated and used advantageous retroviral proteins. The genome has been repeatedly modified through continuous insertion of new retroviruses and repeated insertions with the same or similar retroviruses. As a result, approximately 8% of the human genome is of apparent retroviral origin. Most retroviral integration sites were inactivated through genetic modification (e.g., deletions, mutations) resulting in a variety of residual endogenous retroviral sequences ranging from isolated Long Terminal Repeats (LTRs) to intact simple retroviruses with gag (matrix and capsid proteins), pol (polymerase and other enzymes), and env (envelope proteins) regions. A small number of endogenous retrovirus (ERV) integration sites retained isolated transcriptionally active open reading frames so that a variety of Gag, Pol, and Env proteins may be expressed. The developing placenta is one of few organs that express ERV proteins under physiologic conditions. The human placenta expresses more than 30 different ERV-encoded proteins, including at least 10 different Env proteins1 and assembles some of these into non-infectious virions that bud from the basal surface of the syncytiotrophoblast.2 Similar placental ERV expression has been reported for every mammalian species studied to date, from human to marsupials. Despite decades of research, no physiologic role had been described for any ERV protein until our studies on ERV3.3-5 ERV3 is a single copy ERV genome with an open reading frame in the env region that is expressed during normal human villous cytotrophoblast differentiation.6 Using the villous cytotrophoblast model, BeWo, we determined that stable transfection with env induced expression of β-hCG mRNA and protein that was cAMP/protein kinase A (PKA)-dependent. After the publication of our studies, physiologic roles for two other ERV env elements, HERV-W and HERV-FRD, were described.7,8 Both functioned as typical retroviral envelope proteins and appeared to mediate intertrophoblast fusion. However, a report from deParseval and Heidmann stifled all further research funding on ERV3.9 They identified two adults (1.3% of the sample cohort) with homozygous C to T mutations at position 1354 of the ERV3 env locus resulting in a stop codon (Opl in Fig. 1). This mutation was called a "natural knockout" resulting from blocked expression of a biologically active full-length ERV3 Env. A truncated Env, a p25 molecule, was expressed, but did not contain the biologically active regions found in "typical" exogenous or endogenous retroviral Env proteins. It was concluded that ERV3 Env was most likely irrelevant to placental development. We have now demonstrated that the conclusions of deParseval and Heidmann were inaccurate. Transfection of BeWo with the p25 Env protein induced expression of β-hCG mRNA and protein and reproduced the effects we observed with the intact ERV3 Env (Fig. 2). Why did deParseval and Heidmann, as well as many other investigators, assume the p25 Env truncate was inactive? They were seduced by major paradigms that our data are now challenging. Typical retroviral env, including HERV-W and HERV-FRD, is translated into a large Env precursors (syncytin-1 and syncytin-2, respectively) that are proteolytically cleaved into transmembrane (TM) and surface (SU) subunits; the TM anchors to the plasma membrane and associates with the SU to form a complex that mediates fusion with neighboring cell membranes (Fig. 1). The TM possesses hydrophobic biologically active sites for membrane anchoring and insertion into an opposing membrane (fusion peptide), as well as an immunosuppressive site. Thus, by paradigm, all retroviral Env TM regions possess these biological functions; ERV3 p25, which represents the SU N-terminal region, does not possess the biologically active regions and, therefore, it cannot be relevant to trophoblast differentiation. Our data confirm that ERV3 Env breaks the paradigm; it is a uniquely atypical Env without a functional membrane spanning domain, with a relatively hydrophilic fusion peptide, and an atypical immunosuppressive site.1 Our preliminary data confirm that ERV3 Env possesses a previously unknown biological function in regulation of hormone expression (β-hCG), with the active site contained in the p25 portion (within the SU) of the Env. Our published and preliminary data support a hypothesis that ERV-3 env expression is essential for normal trophoblast differentiation and implantation through regulation of β-hCG expression. The goal of this R21 is to obtain certain critical data must be obtained in support of a future RO1. AIM 1. Mechanism of action of ERV3 Env on β-hCG expression. We will investigate the pathway through which ERV3 env expression affects expression of β-hCG. Preliminary data strongly support activation of a cAMP/PKA-dependent process. We will determine whether this pathway is activated through intracellular complex formation between ERV3 Env and co-factors or accessory molecules. We will also investigate an alternative secreted ERV3 Env-receptor mediated process. AIM 2: Effects of ERV3 env expression of the β-hCG promoter. Activation of the β-hCG promoter may occur secondary to cAMP-dependent transcription factors or directly if ERV3 Env is a transcription factor. Studies will evaluate both potential processes.